INFLUENCE OF IMPROVED GLYCEMIC CONTROL IN OLDER DIABETICS ON ORAL HEALTH

This study is designed to assess the effects of aggressive management of glycemic control by community physicians on oral health status in a group of community-dwelling, older adults with Type II diabetes mellitus who have poor glycemic control. The study will also contrast changes in oral health of diabetics with an otherwise similar group of non-diabetic older adults. The goals are to: (1) investigate whether subjects who attain good glycemic control during a 1 year follow-up period will have a lower incidence of and/or less severe adverse changes in oral health status compared to subjects who do not attain good glycemic control during the follow-up period, and (2) to contrast the incident changes in oral health in diabetics with non-diabetic age- and gender-matched control subjects.